Impact of Geographic Boundaries on Deceased Donor Kidney Discard, Allocation, and Outcomes

PROJECT SUMMARY
For the nearly 95,000 people currently waiting for a kidney transplant, their geographic residence has a
major impact on whether they will get a transplant. Organ allocation is based on geographic boundaries of
donor service areas (DSA) that are artificial. There are 58 DSA in the US, and they vary tremendously in size
and population, which explains some of the variation in access to transplantation. The geographic boundaries
of DSAs were never designed to optimize organ allocation, and do not account for population, prevalence of
kidney disease, or organ donation rates. These geographic boundaries might also contribute to another
important problem – unnecessary discard of donated kidneys. Nearly 20% of all kidneys donated in the US are
discarded. Improving access to transplant and reducing kidney discard are national priorities under the
“Advancing American Kidney Health Initiative.” A new kidney allocation policy that does not use any fixed
geographic boundaries is scheduled for implementation in December 2020. However, the new organ allocation
policy may have unintended effects on organ outcomes and worsen disparities in access to transplant.
This grant will examine three eras of kidney allocation that reveal how the use of geographic
boundaries has affected transplant benefits and equity for patients with end-stage kidney disease: 1) Historical
Allocation Era: Transplants performed before 12/4/2014, when kidneys procured within a DSA were allocated
primarily to recipients within the same DSA; 2) Kidney Allocation System Era (split into two sub eras): Kidneys
considered “lower quality” were shared over a wider region until 9/5/2019, and this policy was subsequently
reversed due to high kidney discard rates; 3) Concentric Circle Era: This system is scheduled for
implementation on 12/15/2020 and eliminates DSA boundaries, and uses a 250-nautical mile radius around
donor hospital to allocate kidneys. The overall objective of this scientific proposal is to determine the effects of
wider geographic sharing of deceased donor kidneys on the specific outcomes of kidney discard, disparities in
access to transplant, and recipient outcomes. My central hypothesis is that systems with wider sharing of
deceased donor kidneys might reduce geographic inequities for patients living in areas with high wait-times,
but it will worsen organ discard and fail to improve kidney allograft survival. These novel insights into the
relationship between geography and kidney allocation could ultimately drive major public health gains for
patients with kidney disease by showing how kidneys can be allocated to improve fairness and increase the
number of transplants.
The applicant has an appointment on the junior faculty at the University of Pennsylvania. With the
support of a highly experienced mentorship team and the ample resources available at the University of
Pennsylvania, his goal is to foster a career of enduring research as an R01 funded independent physician
scientist, and to become a leader in the field of nephrology and kidney transplantation.

Public health relevance
PROJECT NARRATIVE Kidney transplantation enables patients with end-stage kidney disease to live longer and better lives. Yet, where patients live has a major impact on whether they can get a transplant. This grant will evaluate the effect of geography and kidney allocation changes on efficiency and equity in kidney transplantation.